PARP-mediated gene regulation in alcohol drinking behavior

Alcohol use disorder (AUD) is highly prevalent among U.S. military veterans. Excessive alcohol consumption,
defined as the acquisition of a blood alcohol concentration (BAC) ≥ 0.08 g/dl (binging) or ≥ 15 drinks/week for
men, is an important risk factor for many serious medical and psychiatric conditions, including AUD. The
medial prefrontal cortex (mPFC) is important for integrating various internal and external states in order to
determine approach/avoidant behavior to rewarding or aversive stimuli. Prior studies demonstrated that Poly-
ADP ribose Polymerase (PARP), through its ability to regulate synaptic plasticity gene expression, promotes
cocaine addictive behaviors. Whether PARP enzymatic activity plays a similar role in the addictive properties of
ethanol (EtOH) has yet to be studied. The hypothesis of this grant proposal is that EtOH increases PARP
activity causing reduced expression of certain neuronal synaptic plasticity genes in excitatory mPFC neurons
ultimately increasing alcohol drinking behavior. EtOH increases PARP enzymatic activity in cell culture, adult
binging animals, and during fetal development. PARP can silence gene expression by catalyzing reactions
adding PAR groups (PARylation) to downstream gene regulatory proteins, including the transcription factor
peroxisome proliferator-activated receptor-γ (PPARγ) and KDM4D, a demethylase of the transcriptionally
repressive dimethylated lysine 9 of histone 3 (H3K9me2). Examples of genes implicated in AUD that are well-
established to be regulated by H3K9me2 are Brain-derived Neurotrophic Factor (Bdnf) and Pparγ. BDNF and
PPARγ are expressed by excitatory neurons in the cortex, where both have roles in synaptic plasticity and
neuronal survival. Therefore, an alcohol induced suppression of BDNF and PPARγ expression would be
expected to alter mPFC excitatory outputs, promoting continued alcohol drinking behavior. This is supported by
reports indicating higher BDNF expression and PPARγ agonists reduce alcohol consumption. We reported that
PARP activity is in part responsible for EtOH-induced decreases in Bdnf IV and IXa mRNA expression in
primary cortical neuron cultures. We found several lines of evidence indicating that reduced PPARγ promoter
binding may serve as an intermediary step between increased PARP activity and decreased Bdnf expression.
We now propose to examine these same pathways in vivo. Our preliminary data indicate that mice that
voluntarily consumed EtOH in the binge-like drinking-in-the-dark (DID) paradigm had increased PARP mRNA
expression and enzymatic activity in the PFC. DID consumed EtOH reduced BDNF and PPARγ expression,
effects that were reversed by PARP inhibitor treatment. DID EtOH consumption decreased PPARγ DNA
binding ability generally and specifically at the Bdnf IXa promoter. Also, DID consumed EtOH increased global
levels of H3K9me2, and PARP inhibition decreased H3K9me2 at Pparγ and Bdnf IXa gene promoters. Finally,
we found that PARP inhibition reduced EtOH consumption in the DID paradigm. In the first aim, we propose
dissecting the molecular mechanisms connecting PARP to changes in expression of genes involved in AUD in
the mPFC following DID and 2-bottle free-choice drinking paradigms. In the second aim, we will examine the
gene regulatory effects of EtOH-induced PARP in cortical excitatory neurons. This cell specific approach will
utilize the Translating Ribosome Affinity Purification (TRAP) method for RNA isolation, and Fluorescence
activated cell sorting (FACS) isolation of excitatory neuronal nuclei for KDM4D, H3K9me2, and PPARγ binding
experiments. We will also perform data-driven experiments using RNA isolated from excitatory neurons in
transcriptome-wide microarray analysis. In the third aim, we will study the role of PARP in EtOH drinking
behavior, such as DID and 2-bottle free-choice. We will test whether these changes are reversible using PARP
inhibitors and PPARγ agonists. Results of the proposed studies are expected to clarify PARP’s role in
regulating gene expression in relation to AUD. Based on these data it is possible that PARP inhibitors may be
useful pharmacological tools for treating AUD.

Public health relevance
Alcohol use disorder (AUD) is highly prevalent among U.S. military veterans. The molecular mechanisms that underlie alcohol-seeking behavior have yet to be discovered. This project is highly innovative as it examines how the gene regulating enzyme, Poly ADP Ribose Polymerase (PARP), an enzyme induced by ethanol exposure, perturbs gene expression in the medial prefrontal cortex (mPFC). We hypothesize that activated PARP enzymatic activity promotes increased alcohol consumption through changes in mPFC excitatory neuronal gene expression. This study has important clinical implications as there exist FDA-approved drugs that target this pathway that may be able to reverse the underlying gene expression changes caused by ethanol-induced PARP.